Predicting the success of biological control for snail vectors of human schistosomiaisis

Project Summary
Schistosomes are parasitic worms that obligately cycle between human hosts and snail vectors. Transmission
dynamics vary greatly among populations of snails, causing variability in human risk of exposure. Over 200
million people are currently infected with schistosomes, making it the second most detrimental Neglected
Tropical Disease following malaria. There is no vaccine to prevent infection, and drug treatment of infected
patients is limited by emerging drug resistance and the immediate potential for re-infection following treatment.
Therefore, one tool used to prevent infections in humans is biological control of snail populations. One
approach to biological control is the introduction of non-vector snails that outcompete vectors for food
resources. This strategy has been effective in some regions and failed in others. In principle, non-vector snails
should decrease transmission potential of schistosomes to people by diverting searching parasites away from
appropriate vectors (a “decoy effect”) and by decreasing the abundance of vector snails. We hypothesize that
the body size of vector and non-vector snails may be an important yet overlooked trait that explains variable
outcomes in snail biological control. This proposal aims to address these gaps by combining experiments and
mathematical models of schistosome transmission dynamics. The results of this project could help explain the
current shortcomings of biological control with non-vector snails, suggest conditions or strategies that may
improve disease control, and build a framework to evaluate how future snail introductions could affect human
exposure to schistosomes. We will focus on Schistosoma mansoni and Schistosoma haematobium, the two
species of schistosome that together cause the majority of human infections, which only infect snails in the
genera Biomphalaria and Bulinus, respectively. We will use Melanoides as a non-vector competitor snail
because it has previously been intentionally introduced to schistosome endemic regions with mixed outcomes.
In Specific Aim 1, we will use a novel parasite fluorescent-labeling bioassay to determine the vector traits that
influence exposure and susceptibility to S. mansoni and S. haematobium and build a mathematical model to
predict the impact of non-vector and vector body size upon schistosome transmission in multi-species
communities. In Specific Aim 2, we will test these predictions using experimental schistosome epidemics in
snail communities that vary in species composition. This work will allow us to determine the ecological context
in which snail control can aid in human schistosomiasis prevention. Furthermore, our data will allow us to
rigorously test how non-vector snails influence schistosome dynamics in order to guide public health
interventions and management strategies in at-risk regions. Understanding snail ecology is a key step in
combatting this devastating disease worldwide.

Public health relevance
Project Narrative Schistosomiasis is a devastating Neglected Tropical Disease that cycles between human hosts and snail vectors. A key way to prevent infections in people is by controlling snail populations. This project will investigate previously ignored aspects of snail ecology in order to better understand and mitigate human risk of schistosomiasis.